Axially Prestretched Elastomeric Graft (APENG) for Lower Extremity Arterial Reconstructions

PROJECT SUMMARY
This NHLBI R61/R33 exploratory/developmental project aims to develop and test a novel Axially Prestretched
Elastomeric Nanofibrillar Graft (APENG) for lower extremity arterial reconstructions. Lower extremity arterial
disease is a substantial public health burden associated with significant morbidity, mortality, and diminished
quality of life. Advanced stages of this disease commonly require open surgery with synthetic vascular bypass
grafts. While synthetic vascular grafts are generally considered successful, their failure rates in the main artery
in the leg, the femoropopliteal artery (FPA), are unacceptably high. Various advancements in existing graft
technologies have only shown limited improvements in the clinic as they do not address the underlying cause of
complications – the limb flexion-induced kinking and buckling of the graft. Our innovative APENG concept
addresses this problem by incorporating a substantial Axial Prestretch (AP) into the graft. AP is the in-built
mechanism in healthy young FPAs that counteracts limb flexion-induced compression, thereby preventing
arterial buckling and kinking. To achieve physiological levels of AP without inflicting potentially injurious high
axial forces or graft overdilation, we will mimic the anisotropic nature of native FPAs with substantially lower axial
stiffness by inducing circumferential fiber alignment in electrospun APENG. Our preliminary studies support this
concept by showing that APENG prototypes resist buckling and kinking during limb flexion, possess good
surgical handling characteristics, and undergo rapid functional regeneration in-vivo. Our team will employ
benchtop, human cadaver, computational, and large animal models for evaluation and optimization of APENG
prototypes and testing the hypothesis that FPA-tuned APENGs with optimized AP provide reduced limb flexion-
induced buckling, improved flow characteristics, and better functional regeneration than conventional stiff ePTFE
grafts without AP. Our research strategy is focused on reaching specific sequential milestones in the APENG
development and includes measurable deliverables for evaluating progress. Completion of the R61 phase
specific aims will provide physiologically justified functional requirements for the APENG device, refined and
validated manufacturing process, optimized prototypes and surgical procedures, and in-vivo feasibility
assessment. In addition, we will identify an industry Accelerator Partner and secure at least 25% non-Federal
cost matching of direct costs before advancing to the R33 phase. Completion of the R33 phase specific aims
will produce refined APENG design, finalized and standardized manufacturing process, and safety and efficacy
evaluations of the final product against commonly used commercial analogs through standardized in-vitro and
chronic in-vivo studies. Reaching these milestones will lay the groundwork for future larger-scale preclinical and
clinical studies and support professional development and regulatory approval of APENG. This project will also
create new knowledge in arterial and graft biomechanics that can lead to the development of other lower
extremity arterial repair devices and intervention methods offering better and more durable treatments.

Public health relevance
PROJECT NARRATIVE Blockages in the leg arteries are often treated with flexible but non-stretchable synthetic arterial substitutes called bypass grafts. These grafts tend to buckle and kink during limb flexion, promoting new blockages that require repeat interventions. We propose to develop a stretchy synthetic bypass graft that resists buckling similarly to healthy leg arteries and assess its performance during limb flexion using benchtop, human cadaver, computational, and large animal models.